Tracking brain dynamics of the acute stress response and neurocognitive mechanisms of chronic alcohol consumption

ABSTRACT
Excessive alcohol use is a significant and serious public health problem, with 28.6 million US adults meeting
diagnostic criteria for current alcohol use disorder (AUD). The stress response is a promising target for
understanding vulnerability and possible intervention, as risky drinking patterns are deeply and bidirectionally
linked to stress responses. However, key characteristics of the stress response have not yet been leveraged: as
studies to date have focused on individual brain regions and static snapshots of brain responses, we cannot
capture the predictive potential of the multifaceted stress response, which involves widespread interactions
between brain regions and unfolds dynamically over time. Indeed, recent evidence indicates that dynamic whole-
brain responses can provide unique insight into stress-related conditions. The goal of this R01 is to leverage
advances in machine learning and computational modeling to develop and validate whole-brain biomarkers for
stress, and test whether dynamic engagement of these stress networks can predict individual differences in
drinking and alcohol-related cognition. Using a combination of secondary analysis (N = 390) and new collection
of functional MRI data (N = 100), we will identify and validate stress-predictive neuromarkers, capture dynamic
trajectories of stress neuromarkers, and test the consequences of these moment-to-moment dynamics for
cognitive mechanisms driving risky drinking. In Aim 1, we will build a connectome-based model that predicts
responses to multiple modalities of stress exposure in previously unseen individuals using rigorous cross-
validation techniques. We will identify functional connections that predict stress responses in clinically
heterogeneous samples as well as those specific to individuals with AUD. In Aim 2, we will create a novel
moment-to-moment framework to characterize stress response trajectories in the brain and their alterations in
AUD. This framework will enable us to test the hypothesis that, rather than simply having higher or lower
engagement of a stress-predictive network, individuals with AUD will show atypical stress network engagement
trajectories in response to a stressful event. In Aim 3, we will develop a novel neuroimaging paradigm to quantify
the temporal dynamics of brain stress network engagement on memory formation and subsequent drinking. With
this design, we will test the hypotheses that: 1) information that is temporally and conceptually congruent with
stress will be preferentially encoded; 2) dynamic stress networks will co-fluctuate with a validated neuromarker
of attention to facilitate learning; and 3) the timecourse and neural networks by which stress dynamically
modulates learning will differ in AUD and predict future drinking. Together, this work will provide new insight into
the brain’s stress response, including the ways in which its neural architecture (where), temporal dynamics
(when), and consequences for adaptive cognition (how), are predictive of chronic alcohol. The long-term goal of
this work is to develop clinically actionable neurocognitive markers of heavy drinking for early assessment,
intervention, and treatment. Future grants will apply this framework to predict treatment and relapse outcomes.

Public health relevance
PROJECT NARRATIVE Excessive drinking is a significant public health problem that is intricately linked to stress. Although the stress response is a dynamic and widespread brain process, whether these unfolding changes help identify risky drinkers and explain changes in drinking-related cognition remains unclear. The proposed research integrates concurrent functional neuroimaging, neuroendocrine assays, cognitive tasks, and real-world monitoring together with the development of validated stress-predictive brain networks and novel dynamic algorithms to elucidate where, when, and how brain stress trajectories can be used to predict drinking.